Network-Based Novel Therapeutics in Colorectal Cancers

ABSTRACT
Differentiation therapy is a non-conventional therapeutic modality aimed at re-activating endogenous
differentiation programs in cancer cells with subsequent tumor cellular maturation and concurrent loss of the
tumor phenotype. The ‘curative’ power of such therapy has been documented in acute promyelocytic leukemia
(APML), but despite multiple attempts to harness the power of differentiation therapy and its popularity as an
attractive theoretical option, such therapy has not emerged. Among the reasons cited are- 1) incomplete
understanding of the normal stemness-differentiation pathways, and 2) our theoretical inability to pinpoint such
a fundamental, actionable and effective target to drive a complex and nebulous process of cancer-to-normal
tissue transitioning. Using publicly available transcriptomic datasets from adult and pediatric patients with
sporadic and hereditary CRCs and those afflicted with polyposis syndromes and a set of unbiased novel
computational approaches (Boolean analysis and Boolean Networks) an unexpected and novel target was
identified. These computational approaches, which are designed to identify invariant genes that drive
differentiation program in the colon crypts predicted that agonists of the target can trigger differentiation and halt
the initiation and progression, and even induce regression of colorectal adenomas and cancers (CRCs), despite
disease heterogeneity. Expression pharmacology studies using a companion biomarker in FFPE human tissues
confirmed that the pro-differentiation pathway orchestrated by this target is silenced during CRC initiation and
progression. Using a potent and highly specific drug that was previously developed for another indication and
found to be safe in Phase I trials on healthy human adults, it was confirmed that activation of the target is
necessary and sufficient for activation of a pro-differentiation signaling program and in inducing crypt-budding in
colon-derived organoids. This proposal seeks to validate the repurposing of a potent and specific drug for
activating a novel pro-differentiation target, the first of its kind, in the treatment of colorectal polyposis and
cancers. Our specific Aims during the 3-y UG3 phase are all geared towards target validation: obtaining proof-
of-mechanism in healthy murine and human colon-derived organoids (Aim 1); preclinical proof-of-principle
studies using murine genetic models of CRCs (Aim 2); and expression pharmacology and proof-of-concept
Phase ‘0’ trials in patient-derived organoids (pediatric and adults; Aim 3). Successful demonstration of efficacy
in UG3 phase will trigger the UH3-phase (Clinical trial planning; Aim 4).
Although the focus here is on pediatric and adult polyposis syndromes and CRCs, network analysis
revealed the possibility that the proposed therapeutic/indication pairing may transcend other types of cancers.
Much like immunotherapy acts by reinvigorating a physiologic response, the pro-differentiation therapy proposed
here promises to reinvigorate yet another physiologic program; it fulfils a much-needed weapon in our anti-cancer
armamentarium. Their combined synergy when used as adjuvants may elevate response to ‘cure’.

Public health relevance
PROPOSAL NARRATIVE The past 5-decades of treating cancer patients has resoundingly concluded that conventional approaches are not enough to cure most cancers because these approaches fail to ‘kill’ stem cells within tumors; these are the cells that escape by evolving and give rise to metastases and treatment-resistant disease. Differentiation therapy, which is aimed at re-activating differentiation programs in those stem cells has been shown to have ‘curative’ power in a certain type of blood cancer (leukemia), but such therapies are yet to emerge in cancers and remains an elusive Holy Grail and a grand challenge of our times. To tackle this challenge, this proposal seeks to repurpose one drug and validate one of the first differentiation therapies in cancers, and do so by using novel mathematical algorithms and a transdisciplinary approach that begins and ends at the patient’s bedside.